Interventions That Retard Mammalian Aging

PROJECT SUMMARY
Identification of interventions that extend mouse lifespan provides new insights into mechanisms of longevity
determination in mammals and may lay the groundwork for eventual anti-aging therapies in humans. The NIA
Interventions Testing Program (ITP) evaluates drugs proposed to extend mouse lifespan by retardation of
aging or postponement of late life diseases. Interventions proposed by multiple collaborating scientists from the
research community are tested, in parallel, at three sites (The Jackson Laboratory, University of Michigan and
University of Texas), using very similar, standardized protocols, and using enough genetically heterogeneous
mice to provide 80% power for detecting changes in lifespan of 10%, for either sex, after pooling data from any
two of the test sites. One hundred and two such lifespan experiments, involving various doses of 66 distinct
agents, have been initiated in the first twenty years of the ITP. Thirty-six experiments have involved
comparative tests of multiple doses of effective agents, variable starting ages, or alternative dosing schedules.
Statistically significant effects on longevity, in one or both sexes, have been documented and then confirmed
for NDGA, rapamycin, acarbose, 17-α-estradiol (17aE2), and canagliflozin. Significant effects were also noted
for Protandim, glycine, meclizine, captopril, and astaxanthin. Lifespan trials are now underway for 25 new
agents. ITP survival results have also documented longevity benefits from four agents started in middle-age:
rapamycin, acarbose, 17aE2, and canagliflozin. A Collaborative Interactions Program (CIP) has provided
tissues from ITP drug-treated mice to an open, growing, international network of scientific collaborators,
meeting 26 requests from 17 distinct laboratories in the previous five-year period. Plans for the next five-year
period include additional lifespan ("Stage 1") studies, detailed studies ("Stage 2") of drugs found to increase
lifespan, transition from the CIP to an Interventions Biospecimens Repository, additional diagnostic specificity
in pathological assessments, inclusion of RNA-Seq data in all Stage 2 studies, and comprehensive
pharmacokinetic assessments of drugs found to increase lifespan, as well as continued collaborative work with
a network of scientists to study drug effects on postulated aging mechanisms and links to disease. Site-specific
studies at The Jackson Laboratory will add a tests for heart, kidney, and bladder function in Stage 2 studies,
and image analysis of tissues using machine learning. The work proposed should allow the ITP to continue to
make major contributions to mammalian aging biology.

Public health relevance
PROJECT NARRATIVE Testing drugs to see if they increase healthy lifespan in genetically heterogeneous mice is an effective way to find interventions that may alter human aging, because these mice are good models for the clinic, and give reasonably rapid and reliable results, especially when used in three different sites. Identification of interventions that retard aging will suggest research directions leading to clinical treatments designed to prevent or retard deleterious changes with age.